Understanding the Impact of Clonal Hematopoiesis on Aging Human Bone Marrow

PROJECT SUMMARY/ABSTRACT
Every year there are two million new cases of cancer diagnosed in the United States and 600,000 cancer-related
deaths. Preventing the development of cancer, when therapies are more effective, is one of the most potent
methods to decrease cancer-related mortality. While the acquired genomic drivers of cancer are known, it is less
well understood how those genomic changes arise and drive tumorigenesis. Understanding this process may
yield new interventions to prevent malignant transformation from these pre-malignant states. Interestingly, in the
hematologic system, somatic mutations that drive leukemia can be detected at low levels in nearly all disease
free adults—a phenomenon termed clonal hematopoiesis. Clonal hematopoiesis increases in prevalence with
age and is associated with increased cancer risk. However, clonal hematopoiesis is so common that it rarely
progresses to blood cancer and the factors driving leukemic transformation are largely unknown. This also occurs
in other solid organs such as skin and esophagus where clonal mutations are spatially constrained in the tissue.
Prior work has focused on understanding how clonal hematopoiesis arises and evolves over time in the
peripheral blood of healthy individuals. Less is known about how these clones exist and interact within the bone
marrow—the source of hematopoiesis in humans. It is possible that these clones remodel their local niche to
support clonal evolution and leukemic transformation. Intriguingly, given the prevalence and age-dependence of
clonal hematopoiesis, these changes may also negatively affect physiological function to drive aging-associated
changes in the hematologic system (e.g. anemia and declining immunity).
This proposal seeks to understand how these clones exist and interact within the aging human BM niche in
cancer-free adults. This builds upon prior techniques developed for rare mutation detection, single-cell mutation
characterization and immunophenotyping, and spatial mutation detection. In a pilot study of a patient with
hematologic malignancy, applying these techniques demonstrated marked spatial and clonal heterogeneity
within their bone marrow. Now these tools will be applied to examine clonal organization and heterogeneity within
the bone marrow to study “healthy” aging hematopoiesis before blood cancer develops. This study is possible
because of a unique collaboration with Mid-America Transplant, the regional organ procurement organization,
to provide multiple bone marrow containing bones and peripheral blood from brain-dead organ/tissue donors for
this study. This study has the potential to uncover how somatic mutation and aging conspire to drive hematologic
dysfunction, support clone persistence for decades, and drive leukemogenesis directly in human specimens.
The tools developed for this project are broadly applicable to future studies discovering how aging affects all of
the organs within the human body. Long-term, this will identify potentially testable mechanisms to reduce the
risk of malignant transformation and maintain homeostatic organ function late in life.

Public health relevance
PROJECT NARRATIVE In advanced age, cancer and declining organ function are significant drivers of morbidity and mortality. Focusing on the human hematopoietic system, this study aims to investigate how somatic mutations acquired throughout life exist within the cells of the bone marrow and affect the local microenvironment to support clonal evolution, drive cancer development, and adversely affect homeostatic function. By leveraging novel techniques for rare variant detection, single-cell analysis and spatial mutation detection, this study will yield new insights into aging and may identify novel interventions to prevent malignant transformation and preserve organ function late in life.